Family dynamics, maternal stress, and the biomarkers of healthy pregnancy

PROJECT SUMMARY
Global patterns of unequal progress in economic and human development introduce disparities in health at
birth. In the developing world, these changes, accompanied by urbanization, migration, and the nuclearization
of households, are also changing the family context into which children are born. Gaps in health at birth are
not only because of economic inequality: the social support and social status of mothers in their family contexts
are embodied in the health of pregnancies, with consequences for lifelong wellness. However – and despite
the importance of these inequalities for public health – because prior population science has lacked the
population-level biomarkers needed to understand these processes – a comprehensive understanding of
family structure, stress in pregnancy, and disparities in health at birth in the developing world has not
previously been possible. In this mentored project, PI Diane Coffey will pursue training in the biomarkers and
biological processes of stress in pregnancy in the developing world. Training in population-level biomarker
data and stress biology will empower her career as an independent population scientist studying healthy
pregnancy as a start to lifelong wellness. The project has three specific aims. Under Aim 1, Coffey will receive
mentored training in the use of biomarkers in population-level survey data on pregnant women (blood
pressure, obesity, glucose, and hemoglobin), in the biomarkers (cortisol, CRP) and biology of stress in
pregnancy, and in biostatistics. She will complete an extensive program of coursework and guided reading,
and attend workshops and conferences on biomarkers to analyze data for pregnant populations. Aim 2 is for
the PI to conduct within-population studies of consequences of household structures for biomarkers of stress in
pregnancy and birth outcomes. One part of Aim 2 will study the importance of three-generation households;
another part will investigate the consequences of partner absence. Aim 3 is construct international
comparisons and inform theory by comparing outcomes in countries with different forms and intensities of
gender discrimination. Achieving these three aims will prepare the PI to apply for future R01 support as an
independent population scientist. The resulting research agenda will add new biosocial root causes to existing
models of early life health disparities and assessments of the global burden of disease.

Public health relevance
PROJECT NARRATIVE Throughout the developing world, health disparities begin at birth, in part because social discrimination and family contexts influence the health of pregnancy. In this mentored training project, PI Diane Coffey will be trained in the use of biomarkers and in the biology of stress as it relates to pregnancy. Such training will empower a research agenda that uses demographic data to explain inequalities in lifelong wellness as resulting, in part, from social and family structures that are embodied in biologically-measurable dimensions of healthy pregnancy.